2015 Nucleosides, Nucleotides & Oligonucleotides Gordon Research Conference and Seminar

? DESCRIPTION (provided by the applicant): This application requests partial support for a meeting on Nucleosides, Nucleotides, and Oligonucleotides as part of the Gordon Research Conference series to be held in Salve Regina University, Newport, RI from June 28, to July 3, 2015. The broad and long term goal of the conference is to increase our understanding of the chemistry and biology of nucleosides, nucleotides, and oligonucleotides. The specific aims of this meeting will be to convene nine discussion leaders to moderate nine sessions. The chair (Vern L. Schramm) and vice- chair (Cynthia Burrows) will supervise the organization and operation of the conference. There will be a total of 29 invited speakers who will represent critical areas of the chemistry and biology of nucleosides, nucleotides, and oligonucleotides and 8 oral student/postdoctoral presentations. The program will have a keynote lecture and eight sessions that broadly address current issues in nucleic acid chemistry, DNA repair, discovery of anticancer and antiviral agents, synthetic biology, nucleotide metabolism in bacteria, enzymology of purine and pyrimidine metabolism, and RNA metabolism. The keynote lecture will be given by Dr. Andrew Fire, who won the Nobel Prize in Chemistry in 2006 for his work on the discovery of RNA interference (RNAi). In addition, evening poster sessions will encourage all attendees to contribute. Gordon Conferences provide numerous opportunities for young investigators, women, and minorities to interact with senior leaders in the field. Participation of young scientists will be fostered by a Gordon Research Seminar to be held the weekend prior to this conference. Students and postdoctoral fellows organize the seminar to build peer group relations and solidarity. The significance of this application is that the Gordon Research Conference is the only platform where chemists and biologists who focus on nucleosides, nucleotides, and oligonucleotides come together. Nucleoside analogs, acting by diverse mechanisms, are highly effective for the treatment of viral diseases, cancer and other infections. Agents for HIV, Marburg and Ebola viruses are topics of interest. In addition, nucleic acids analogs as siRNA, miRNA, antisense, catalytic RNA belong to one of the most exciting new areas in drug development. Besides becoming major tools for prognosis and diagnosis of various diseases, oligonucleotides are also used as new tools in epigenetics, synthetic biology and systems chemistry, which will become important technologies for generating new drugs for the future. Additionally, understanding the chemical mechanisms of DNA damage and repair advances our knowledge of cancer etiology for both prevention and treatment. The conference will focus on all these new areas and will be a discussion forum and an exchange platform for generating new knowledge and collaborations. This conference is therefore highly significant regarding its health relatedness. The discussions among chemists and biologists will generate new knowledge and avenues for development of novel therapeutics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Numerous drugs currently used to treat viral infections, cancer, bacterial and protozoan infections, and metabolic disorders work by inhibition of enzymes involved in nucleic acid metabolism. The goal of the Nucleoside, Nucleotide & Oligonucleotide Gordon Research conference is to increase our understanding of the chemistry and biology of all aspects of nucleic acid metabolism to help investigators learn about the newest developments in this field. There will be numerous opportunities for young investigators, women, and minorities to enhance their understanding in the field and to interact with senior leaders in the field.